Allele-specific analysis of human epigenome, transcriptome and high-resolution chromatin organization

Abstract
The human genome has two alleles at each genetic locus, with one allele inherited from each parent. Allele-
specificity has been widely observed and investigated across human transcriptome, epigenome and 3D chromatin
organization respectively, as evidenced by the data collected from the GTEx project, the ENCODE project, and the
4DN project. However, the allele-level interplay among transcriptome, epigenome and 3D chromatin organization
has not been systematically explored. In the proposal, we aim to leverage shared donors between these
consortia and systematically investigate these connections at allele-level in many human tissue types. With
the single cell datasets available from these donors, we will narrow down from tissue level to cell type level,
and further interrogate these allele-specific cross-modality connections. In essential, our analysis seamlessly
integrates two NIH Common Fund datasets, namely 4DN and GTEx datasets, and ENCODE datasets. With this
integrated data source, biomedical researchers can easily navigate, browse, compare and investigate the high
quality, high resolution, and comprehensive datasets regarding chromatin organization, regulatory elements,
epigenomic status and transcriptional activity with allele-specificity and cell-type-specificity. Not only would this
accomplishment have an enormous positive impact on the utility and usage of the Common Fund datasets, it
would also help to promote open science and reproducible research in the areas of computational genomics and
data science.

Public health relevance
Project Narrative The goal of this project is to develop novel computational approaches to jointly analyze 4DN datasets together with GTEx datasets and ENCODE datasets in an allele-specific manner. The integrative analysis will be critical to unveil the mechanisms of the genetic variants and the human genome. The new knowledge gained here could help us understand the genetic basis of many human diseases.